Emory/Georgia TB Research Advancement Center (TRAC)

The overarching goal of the Clinical & Population Science Core (Clinical Core) is to accelerate data-driven
solutions to the persistent challenges of domestic and global TB control. To meet this goal, the Core’s strategic
imperative is to promote innovative research on TB by fostering new collaborations and by expanding existing
collaborations among scientists across diverse disciplines at Emory University, University of Georgia (UGA),
other partner institutions in Georgia, and internationally.
A major strength of the Emory/Georgia TRAC is our long-standing, productive research partnerships with
both international (Ethiopia, Uganda, Kenya, South Africa, Philippines, and the country of Georgia) and
domestic sites (DeKalb and Fulton County Boards of Health; U.S. Centers for Disease Control and
Prevention). These research sites provide clinical care to diverse patient populations, have state-of-the-art
laboratories and data management systems, and are directly engaged in translating research into policy at the
local, national, and global levels. Clinical Core faculty are world-renowned TB scientists with successful track
records of leading impactful clinical and epidemiologic research in TB/HIV, drug-resistant TB, TB transmission,
pediatric TB, TB/diabetes, and post-TB lung health. Their cutting-edge work has integrated innovative
epidemiologic and biostatistical methods to advance our approach to TB research, including geospatial
methods, network analysis, bias analysis, epidemic modeling, and molecular epidemiology. This extensive
research portfolio also provides investigators with access to curated research databases, organized specimen
repositories, and field-tested study instruments. The Clinical Core will leverage these resources and expertise
to enable the conduct of scientifically rigorous, multi-disciplinary TB research by early stage investigators and
established investigators new to TB. In this way, the Core will catalyze the next generation of TB researchers,
improve our understanding of TB, and support the needs of new and emerging science.
In three integrated Aims, the Clinical Core will support high-impact research by facilitating access to
diverse study populations at international and domestic clinical research sites through a comprehensive
program that will introduce, establish, and nurture relationships between TRAC investigators, our collaborating
partners, and early-stage and established investigators new to TB. The Core will provide consultation and
training to investigators undertaking new clinical, epidemiologic, or translational research in TB through end-to-
end support for study planning, implementation, and dissemination. The Core will develop a centralized
repository of research data and associated Mtb isolates and specimens that links with the Basic Science Core
biorepository, providing numerous opportunities for innovative clinical and translational analyses. The long-
term goal of the Core is to cultivate a robust TB clinical research environment that is accessible, impactful, and
collaborative to grow the pool of TB investigators conducting transformative research within the TRAC.